Application of Hyperpolarized 13C Magnetic Resonance Imaging to Detect Target Inhibition of NF-kB Activation and Response in Primary CNS Lymphoma

PROJECT SUMMARY/ABSTRACT
This proposal will apply an innovative metabolic imaging approach, hyperpolarized (HP) 1-13-C MRI to address
NF-kB activation in cancer. NF-kB is a key pro-survival transcriptional regulator that drives resistance in a variety
of malignancies, one of which is primary CNS lymphoma (PCNSL) a highly refractory form of activated B-cell
(ABC)-type large cell lymphoma. ABC-type large cell lymphomas are an important cause of cancer-related
mortality worldwide. Recent trials using targeted agents that block NF-kB activation have shown activity in
PCNSL and systemic ABC-type lymphoma, yet responses last only a few months, suggesting that alternative
pathways of NF-kB activation are adaptively induced to mediate resistance. We hypothesize that HP 1-13-C
MRI may have particular utility in detecting clinical response, defining prognosis and target inhibition in PCNSL
and can also be applied to identify effective combinatorial strategies that durably suppress NF-kB activation. In
addition, we envision that this approach may be impactful in identifying biomarkers that predict efficacy of
immunotherapy. Our team recently demonstrated for the first time the feasibility of HP 1-13-C MRI to image
malignant glioma in patients. These studies support the potential of HP 1-13-C MRI to identify metabolites that
yield impactful non-invasive biomarkers of in vivo metabolic processes in PCNSL, including resistance pathways,
with markedly improved sensitivity and specificity compared to standard MRI. We have recruited a talented,
multidisciplinary team to pursue this highly translational project to address key gaps in PCNSL research through
pursuit of the following specific Aims:
1) Test the hypothesis that hyperpolarized (HP) [1-13-C]-metabolic MR imaging of genetically-defined, patient-
derived orthotopic models of PCNSL can non-invasively evaluate depth of response to combinations of NF-kB
targeting agents as well as provide an early biomarker of the emergence of resistance.
2) Test the hypothesis that HP [1-13-C] metabolic MR metrics can be developed as non-invasive biomarkers of
NF-kB-activation and immunosuppression in a syngeneic, immunocompetent model of PCNSL.
3) Perform the initial proof of principle patient studies of HP 13C MRI to determine feasibility and methods of HP
[1-13C] pyruvate MRI as a real time, non-invasive imaging tool for response assessment in PCNSL.
We will correlate genetic markers of NF-kB activation in tumors with lactate on HP 13C MRI and lactate in
cerebrospinal fluid and their relationship to progression-free survival. These studies will constitute a basis for
integration of HP13C metabolic imaging in the research of PCNSL, and of ABC-type lymphomas in general, to
improve detection, prognostication, identify resistance, and facilitate precision medicine. We anticipate these
studies will identify novel combinations and schedules of agents that durably block NF-kB, to be tested in the
clinic. These studies may also provide a rationale for implementation of tumor lactate as a novel biomarker for
immunotherapy trials. Ultimately our studies may stimulate multicenter trials to evaluate HP 13C MRI in PCNSL.

Public health relevance
PROJECT NARRATIVE Primary CNS Lymphoma is an aggressive form of activated-B-cell type large cell lymphoma, an important cause of cancer-related death worldwide. Activated B-cell lymphomas are driven by NF-kB, a key pro-survival pathway. We are implementing an innovative metabolic imaging approach, HP13C MRI, to dissect the pathogenesis of NF-kB in primary CNS lymphoma: to identify novel and more effective combinations of NF-kB targeting agents and to identify novel biomarkers that may predict resistance to immunotherapy. We will also perform the first clinical trial of HP13C MR in primary CNS lymphoma patients to evaluate its potential to facilitate diagnosis, prognostication, and ultimately precision medicine.